Integrative Analysis Core

Project Summary: Integrative Analysis Core (IAC)
Longevity and age-related traits and diseases such as Alzheimer’s disease and related dementias (ADRD) are
multifactorial and ultimately influenced by many interacting genetic and non-genetic factors. This challenges the
identification of mechanisms that influence human lifespan and healthspan. Addressing this challenge requires
strategies to integrate and triangulate results from different studies. Such integration can lead to verification of a
finding, as well as placing a finding into a broader context to gain a deeper understanding of longevity related
physiology. The Integrated Analysis Core (IAC) of the Longevity Consortium (LC) will seek to integrate the results
of 5 different research projects (P1-P5), each addressing a key objective in the RFA: P1 studies diverse human
populations to determine the contexts within which longevity-related factors exhibit associations; P2 studies
genomically-mediated evolutionary processes contributing to longevity; P3 studies extreme longevity (EL) and
its relationship to ADRD in diverse human populations; P4 studies aging rate indicators in response to candidate
geroprotective drugs in mice; and P5 studies novel cell systems and constructs derived from individuals with EL
and other longevity related phenotypes. The IAC will seek to integrate results and data across these projects by
developing appropriate infrastructure and analytical methods and engaging in analyses with the project
researchers, including: 1. Developing connections, collaborations, and infrastructure to access data from
different sources to enhance P1-P5 research, and also work with the NIA-funded Data Management and
Coordinating Center’s (DMCC) Exceptional Longevity Translational Resources (ELITE) portal team to enable
broader access to relevant data sets; 2. Develop and apply methods for harmonizing data when needed,
accommodating heterogeneous data sets when harmonization is impossible, and dealing with the analysis of
complexities associated with large, diverse data sets; 3. Develop and apply systems biology and result
triangulation methods; 4. Develop strategies for leveraging genetics and genomics data to enhance cross
population comparisons via individual ancestry assignments, orthology determination to enable integration
across studies of different species, and genetic association studies involving complex phenotypes; and 5.
Coordinate and support a broad translational workflow leading from the identification of longevity-associated
factors to geroprotective drugs, drug targets, clinically meaningful biomarkers, and predictive models of health
and longevity.